APPLICATION OF DIFFERENT SOLVATION &ELECTROSTATIC MODELS TO UBIQUITIN

I am interested in how different solvation or electrostatic models influence the results of molecular dynamics calculations. As an example, I investigated the protein ubiquitin, that due to its small size allows the calculation of long trajectories in a reasonable amount of computer time. To simulate the effect of the surrounding solvent, one can use either a periodic box or a small shell of explicit water molecules around the biomolecular system. Another important issue is the treatment of the long-range electrostatic interactions during a MD simulation. Here, the use of an Ewald summation scheme leads to trajectories that stay much closer to the initial protein crystal structure than conventional cutoff schemes. The Computer Graphics Laboratory is important for the visualization of both the initial setup of the calculations and of the results obtained.